Community Partners

Black mothers are often excluded from the very research designed to improve their health and health
outcomes, despite the fact that they carry the worst burden of maternal mortality (MM) and severe maternal
morbidity (SMM) in the US and especially the Gulf South. Mistrust rooted in a history of discrimination,
experimentation, and stereotyping contributes to the present-day disparities. It is imperative that the proposed
program incorporate institutions who are embedded within the priority population as partners with the research
and healthcare cores of the Center. This will be accomplished by establishing equitable partnership
agreements that counteract the paternalistic framework of traditional research centers. This project’s primary
community partner–not only in this Core but across the entire Center and its leadership–is the National Birth
Equity Collaborative (NBEC). NBEC is nationally renowned for its unique ability to bridge communication gaps
between healthcare systems and Black birthing people via trainings, research, advocacy, and community-
centered collaborations. By also working with community-based organizations (CBOs) primarily led by and
serving Black women, we will have greater access to the target population, and help build these organizations’
capacity via technical assistance Furthermore, our partnerships with Ochsner Health System and other
healthcare partners will aid in translation of findings and sustainability of programming or potential policy
changes. The long-term goal of this Core is to reduce disparities in MM and SMM by embedding Community
Partners into all facets of the Center’s activities. Crucial to the project’s success is our overall objective to
elevate Black voices by incorporating Black-led Community Partners as equal partners in research- and
training-based efforts. Our overall hypothesis is that effective maternity care and interventions can be achieved
when they are founded on research that is guided and co-led by community organizations who fill the gap in
collaboration between health systems and Black communities. To achieve our objective, we will pursue the
following Specific Aims: 1) Establish equitable partnerships between the CBO, researchers, and healthcare
providers through collaborative research projects and training programs within the Center; 2) Create a
research training laboratory where Community Partners and researchers are learning in partnership and
synergizing their knowledge and experience, assets, and networks to achieve the overall objective; 3) Facilitate
the translation and dissemination of efficacious prevention, treatment, and policy focused on reducing racial
inequities in MM and SMM and the root causes of these disparities. Positioning NBEC as the primary
Community Partner and equal collaborator will not only significantly improve the project’s design,
implementation, and dissemination efforts but will also forge strong and lasting relationships with the target
population that will ultimately result in better healthcare outcomes. Prioritizing capacity building efforts with our
Community Partners will generate sustainable and system-level changes throughout the Gulf South.